Transcriptome Analysis of Identified Cells in Developing Xenopus laevis CNS

DESCRIPTION (provided by applicant): Xenopus laevis has been a valuable model system for studying neural development. In more recent years its utility has been eclipsed by other model systems simply because it lacks the genetic tools required for molecular and cellular manipulations. Nevertheless, many features make Xenopus a unique and irreplaceable model for studying, manipulating and testing neuronal developmental paradigms in vivo. The focus of the proposed studies is threefold: 1) to provide the Xenopus community with much needed genetic information on the sequence and expression of gene transcripts and microRNAs in several regions of the X. laevis brain, in several identified neural cell types and at several developmental stages, 2) to generate reagents for molecular/genetic manipulations of identified transcripts and signaling pathways, including antisense morpholino constructs, siRNA and cell-type specific expression of genes of interest and 3) to use the reagents to probe the function of candidate regulatory genes in neurogenesis in the intact animal. The proposed work will generate a wealth of reagents that will significantly enhance use of Xenopus as an experimental model for biomedical research and permit cross-species comparative studies that will enrich research in other experimental systems.

Public health relevance
This project will characterize the transcriptome of identified cells in the brain of developing Xenopus laevis tadpoles using whole transcriptome sequencing to identify genes that are differentially expressed in targeted neural progenitor cells. Using the sequencing data we will develop appropriate expression constructs, siRNA constructs and antisense morpholinos to probe the role of candidate regulatory genes in neurogenesis in vivo. These studies will provide new genomic resources for the Xenopus community and promote the use of Xenopus as an experimental system to study developmental brain disorders.